Screening and Survey Instrument Development Core

ABSTRACT: Screening and Survey Instrument Development
The National Dementia Workforce Study (NDWS) will be launched by a national team of experts in clinical care
of persons living with dementia, survey research, and health workforce research. The goal of the NDWS data
infrastructure is to allow researchers and policymakers to ask and answer scientific questions to help build the
workforce of clinicians and other professional care providers required by the growing population of persons
living with dementia in the U.S. The Screening and Survey Instrument Development Core will develop the
survey content and procedures to launch four nationally representative surveys of Community Clinicians,
Nursing Home Staff, Assisted Living Staff, and Home Care Staff. This team will: 1) Develop sampling frames
for the four NDWS surveys from data sources including national Medicare and Medicaid claims and
assessment data to create efficient sample designs; 2) Develop questionnaires targeting specific professional
workforce providers relevant to the particular survey setting (e.g., physicians, nurses, direct care workers) with
a focus on training, compensation, payment models, and care practices; 3) Test questionnaires using focus
groups, cognitive interviews, expert review, and several innovative online methods in order to ensure reliable
and valid measurement; and 4) Develop a process to solicit proposals for new items to be added to ongoing
surveys.